Center for Translational Research on Aging

ABSTRACT
Kuakini Medical Center (Kuakini) proposes to develop a multidisciplinary Hawai'i-based Center of Biomedical
Research Excellence (COBRE) for translational research on aging. This Center will draw on the most
promising junior investigators from across the state with cross-institutional and interdisciplinary collaborative
efforts between Kuakini, the University of Hawaii John A. Burns School of Medicine (JABSOM), and major
academic research centers and medical centers. It will cross institutional borders to promote research aimed at
improving human healthy lifespan (healthspan) and ameliorating major age-related diseases, including
cardiovascular diseases, cancer and dementia, in people of Hawaii, the U.S. mainland and around the world.
The Center will build upon the strengths of Kuakini's five-decade track record of NIH-funded research, its
420,000-specimen biorepository, and its existing strengths in aging research, notably, the 51-year long Kuakini
Honolulu Heart Program (Kuakini HHP) and Kuakini Honolulu-Asia Aging Study (Kuakini HAAS), and Kuakini
HHP Offspring Study. This will advance translational aging research and foster meaningful solutions toward the
disease and disability associated with the aging process.
We will pursue this long-term goal via the following specific aims:
 Specific Aim 1: Create a world class, innovative, interdisciplinary Center for Translational Research
on Aging (CTRA) by building on the existing rare and valuable Kuakini Honolulu Heart Program
(Kuakini HHP) and its related studies, existing Kuakini HHP Offspring Study, and research
infrastructure.
 Specific Aim 2 - Advance the genomic, biological and clinical science of aging, and enhance the world
class character of our proposed Center, by enlisting accomplished senior scientists to mentor promising
Hawaii-based junior investigators in interdisciplinary research and career development.
 Specific Aim 3 - Elevate the capacity of our Center by: i) creating a state-of-the-art Clinical and
Translational Core, and ii) collaborating with other Centers of Biomedical Research Excellence.
The Clinical and Translational Core will expand upon the strong epidemiologic, genomic and clinical work of
Kuakini HHP and related studies and the Kuakini HHP Offspring Study; benefit investigators in the State of
Hawaii and abroad, and foster translation of basic science and clinical findings into novel applications and
therapeutics for healthy aging. COBRE funding will be leveraged with institutional commitments to accelerate
the development of research excellence. The Center will collaborate with three other Hawaii-based COBREs,
the COBRE Mouse Phenotyping Core, and the INBRE-funded Bioinformatics and Biostatistics Core at the
University of Hawaii.

Public health relevance
NARRATIVE – OVERALL SECTION Kuakini Medical Center (Kuakini) proposes to develop a multidisciplinary Hawai'i-based Center of Biomedical Research Excellence (COBRE) for clinical and translational research on aging. This Center will draw on the most promising junior investigators from across the state with cross-institutional and interdisciplinary collaborative efforts between Kuakini, the University of Hawaii John A. Burns School of Medicine (JABSOM), and major academic research centers and medical centers. It will cross institutional borders to promote research aimed at improving human healthy lifespan (healthspan) and ameliorating major age-related diseases, including cardiovascular diseases, cancer and dementia, in people of Hawaii, the U.S. mainland and around the world.